Substance Use and HIV Prevention Research in Minority Communities Training Program

ABSTRACT
This application seeks continuation of funding for the Substance Use and HIV Prevention Research in Minority
Communities program (SUHPR) at the University of California San Francisco (UCSF). SUHPR addresses the
urgent need to promote clinical prevention research and reduce health disparities in marginalized communities
where substance use is a crucial public health concern. SUHPR also aims to increase the number of scientists
from diverse backgrounds who attain NIH funding. Specifically, SUHPR will:
1) Increase visiting professor (VP) trainees' capacity to conduct interdisciplinary clinical research that
elucidates and addresses the links between substance use and HIV in marginalized communities in line with
NIDA and the NIH Office of AIDS Research (OAR) priorities;
2) Fund pilot studies to provide preliminary data for grant proposals;
3) Assist in the development of VP research careers and skills and the conceptualization, writing, submission,
revision, and resubmission of NIH grants that focus on substance use, HIV prevention, and HIV care
outcomes, via mentoring meetings, seminars, webinars, and peer networking; and
4) Sustain and expand the research programs of former VPs by engaging them via peer reviews and writing
retreats, while leveraging their experience as peer reviewers, mentors, and collaborators.
Aims 1-3 will be accomplished through VPs participating in a three-year summer intensive program at UCSF.
Each VP will visit UCSF for six weeks per summer for three summers, attending seminars on HIV and
substance use research, methods, and grant writing. In the first summer, faculty mentors and peer VPs will
assist each VP to develop their research ideas into feasible research applications (Aim 1), develop a plan for
their pilot study (Aim 2), and begin drafting an NIH grant proposal (Aim 3). VPs will then initiate the pilot studies
during the academic year following the first summer. In the second summer, VPs will complete and submit their
NIH grant proposals. Following the second summer, VPs will present pilot study findings at scientific
conferences and draft manuscripts for publication submission. During the third summer, VPs will revise and
resubmit the proposal in response to NIH reviewer feedback. If VPs receive NIH funding prior to the third
summer, the VP program will mentor them in study start-up activities to enhance the rigor and likely success of
their NIH-funded studies. Between summers (during the academic year), faculty mentors will communicate with
VPs at least monthly, supplemented by webinars and virtual writing retreats. To fortify this intensive research
education experience, the SUHPR program will provide scientific peer reviews and consultations after the third
summer to help VPs from diverse backgrounds remain in the research pipeline and extend their innovative
programs of substance use and HIV research (Aim 4). We will involve successful former VPs for peer reviews,
mentoring, and collaboration activities with current VPs.

Public health relevance
PROJECT NARRATIVE Research to advance understanding of the development and progression of diseases and disabilities such as substance use and HIV that contribute to health disparities is a major goal of the National Institutes of Health's strategic research plan to reduce and ultimately eliminate health disparities. Innovative, evidence- based interventions that rely on well-researched and culturally-specific theories of human behavior are urgently needed to stem the rising tide of HIV and substance use. The Substance Use and HIV Prevention Research in Minority Communities research education and mentoring program aims to address this urgent research need through offering seed funding to promising clinical scientists to conduct applied research studies and a mentoring infrastructure to empower these scientists to successfully apply for and receive NIH funding to conduct rigorous, multiyear research projects in the communities most affected by the HIV and substance use epidemics.